Ligand Gated Ion Channels Across Time and Space

PROJECT SUMMARY
Ligand-gated ion channels (LGICs) enable cells to fine-tune their intracellular space based on environmental
cues and cell-cell communication. Because of their role in regulating cells, dysregulation of LGICs is a major
contributor to human diseases. LGICs function through binding chemicals in their extracellular domain, which
opens their ion channel, enabling ion flux into cells. The mechanisms of how this occurs is referred to as gating.
Because LGIC function enables our cells to react to environmental cues, they must gate on a rapid, millisecond
timescale for proper function. However, it is unknown how LGIC gating occurs on this timescale because
technological limitations have precluded the physiological mechanisms of gating from being studied. In addition,
the function of LGICs is tightly regulated by auxiliary proteins in cells, which localize the function of LGICs in
cells and provide a mechanism for cells to further control gating. Despite the importance of auxiliary subunits to
fine-tune LGIC function, the mechanisms of how auxiliary subunits regulate LGICs are unclear. Furthermore,
how therapeutics regulate LGIC function is unknown. Our research addresses these major knowledge gaps and
will uncover the mechanisms of how LGICs gate, how function is regulated, and provide vital foundations for
targeting LGICs with therapeutics to treat human diseases. To initiate our research, we are focusing on AMPA
receptors (AMPARs), which are a subtype of LGIC that mediate neuronal communication, and dysregulation of
AMPARs is a major driver of neurological diseases. To understand how AMPARs function on a physiological
timescale, we developed a time-resolved cryo-electron microscopy (cryo-EM) approach that enables us to study
AMPAR and LGIC function with millisecond resolution in this proposed research. Our research here will form the
molecular and structural basis of how AMPARs gate. We will also elucidate how AMPAR gating and localization
is regulated by auxiliary subunit proteins, which is a major regulation mechanism of AMPAR function, but the
details are unknown. We will uncover these mechanisms with cryo-EM, biophysics, and electrophysiology. We
will also use these approaches to understand the mechanisms of how therapeutic molecules alter AMPAR
function. Collectively, our findings will uncover the precise molecular details into how AMPARs function and how
AMPARs are regulated in health and disease, as well as provide us with critical avenues for studying LGICs in
our future research.

Public health relevance
PROJECT NARRATIVE Ligand gated ion channels are proteins that enable our cells to fine-tune their intracellular environments based on chemical cues, and the dysregulation of these proteins is a major driver of human disease. The details of how ligand gated ion channels function are critical to understand for therapeutic design, yet despite their importance, the mechanisms of function are unclear. We are elucidating the molecular mechanisms of how ligand gated ion channels function to understand how they regulate our cells in health and provide foundations for disease treatment.